Analytical Core

REVISED ABSTRACT
The Resource Center for Alzheimer’s and Dementia Research in Asian and Pacific Americans (RCASIA) has missions of 1) increasing early career scientists in AD/ADRD-related Behavioral, Social, and Economic Research biomedical research through innovative models of mentoring and community interaction; 2) advancing the rigor and impact of AD/ADRD pilot studies in older APAs through Common Data Elements and data-sharing; 3) serving as a national resource for linguistically/culturally tested and validated tools to assess cognition, function, and AD/ADRD care in APA populations. The Measurement and Analytical Core (AnC) – led by Stephen Crystal, PhD and Donald Hoover, PhD – will oversee the analytical infrastructure of RCASIA to support RCASIA Scientists in their pilot study design, analysis, and modeling; introduce rigor and reproducibility into pilot measures through a linguistically/culturally-grounded framework; participate in Pod meetings to guide measurement-related discussions; support the collection of Common Data Elements, the free web-based universal Clinical Research ID, and data-sharing; continue to support data requests for the Population Study of Chinese Elderly (PINE); and hosts the repository for linguistically/culturally tested/validated instruments. The AnC will build on its expertise in health services research, fit-for-purpose primary data analysis, harmonizing large secondary datasets, and partnerships with specialized analytical experts to help RCASIA Scientists complete their pilot projects and build new collaborative projects. Two current Center-based innovations – due to complete in FY 2022 – will also be available for Scientists’ use: probability-based APA subgroups from linking Medicare data with American Community Survey, and the linked survey-genomic data from Health and Retirement Study. Finally, the AnC will report on the acceptability of Common Data Elements and universal Clinical Research ID towards the eventual goal of a future pilot RCASIA Research Registry for older APA in the NYC/NJ area.